Administration, Communication and Integration Core

The Translational Center for Serotonin and Stimulant Addiction (TCSSA) will address the large gap between the beliefs that 5-HT is involved in addictive processes and the mechanisms through which 5-HT function and dysfunction actually contribute to addictions and their treatment. The Administration, Communication and Interpretation Core (Core A) will play a critical role in this process by promoting and enhancing synergy among all players in the proposed translational Center. The Administrative Core will facilitate TCSSA functions and will meet the administrative needs of the faculty, staff, and trainees within the Center, including oversight of TCSSA organization and logistical and integrative processes. The philosophy behind this structure is the belief that the success of the TCSSA is heavily dependent upon the interconnections and communication among all components. The overall goals of the Administrative Core are to: (1) create the necessary administrative infrastructure to empower efficient TCSSA function and to ensure sound fiscal management and appropriate compliance and reporting;(2) create a productive community of translational scientists in an intellectually dynamic, productive and interactive milieu through a unified communication and collaboration plan;(3) provide strategic guidance to the Projects and Scientific Core in the planning and evaluation of research, and to assure adherence of the individual Projects to the theme of the TCSSA;(4) facilitate translational training and mentoring goals;(5) maintain a TCSSA-specific, restricted-access website which will allow coordination of planned experiments, data distribution and data integration;(6) serve as liaison to the Leadership Team and External Advisory Board and implement their recommendations;(7) serve as a centralized structure for coordination of data and resource distribution. Core A will be instrumental in assuring that the collaborative, transdisciplinary initiatives proposed here are pursued systematically and that the products of our translational efforts are shared with the scientific community. In all of these activities, the Administrative Core will function with integrity, following the recommendations of the Leadership Team and the External Advisory Board. The Administrative Core will assure that maintaining quality control, improving efficacy and enhancing productivity will be permanent, dynamic components of the TCSSA. Lav Abstract. The Administrative Core (Core A) of the TCSSA will be instrumental in assuring that the collaborative, transdisciplinary initiatives proposed are pursued systematically and that the products of our translational efforts are shared with the scientific and lay communities in a timely manner.